Point-of Care MR Device to Estimate T1 Relaxation Time as a Biomarker of Liver Disease (resubmission)

PROJECT SUMMARY
LiverScope® is a low cost, easy-to-use, table-top device for use in research and clinical settings to assess
quantitative biomarkers of nonalcoholic fatty liver disease (NAFLD). It uses novel, noise-free, advanced
magnetic resonance (MR)-based technology, requires no room shielding, and can be sited in a standard clinic
room for point-of-care (POC) access or can be operated in a small van for mobile diagnostic delivery. We
recently received a Phase 1 SBIR grant (1 R43 DK135225-01) to show feasibility of using LiverScope® to
estimate liver PDFF, and are now re-submitting this current Phase 1 SBIR proposal to show feasibility of
LiverScope® to estimate liver T1 relaxation times. Emerging data support use of T1 relaxation time as a
quantitative biomarker in numerous contexts of use, including diagnosis of ‘at risk NASH’, treatment response,
monitoring, stratification, and prognostication. Adding T1 relaxation time estimation capability to LiverScope®
has the potential to make it a ‘one-stop’ test, substantially enhancing its clinical, scientific, and commercial
value. Demonstration of non-invasive imaging biomarker assessment feasibility of both hepatic steatosis (by
PDFF) and fibrosis/inflammation (by T1) will support a follow-on comprehensive Phase 2 trial in which these
biomarkers of NASH can be tested prospectively. Our long-term goal is to bring LiverScope® to market. Our
focus in this study will be to develop LiverScope® capability and establish feasibility to estimate T1 relaxation
time (T1). Our immediate goal in this study is to evaluate T1 precision for two identical LiverScope® devices,
and so our primary specific aims are to estimate water T1 intra-device repeatability and inter-device
reproducibility in phantoms (Aim 1) and humans (Aim 2). The innovation of this proposed derives from the
novel technology used to estimate and verify validity for MR-based quantitative biomarkers of NAFLD at low
cost and in POC settings while maintaining the accuracy and precision of full-size MRI scanners. The clinical
significance of this work is that widespread implementation of this technology will enable earlier diagnosis,
more timely referral to specialists, and greater access to monitoring of NAFLD. If these studies are successful,
deployment of LiverScope® in primary care, rural, underserved, and third-world communities will be possible.
Offering real-time PDFF and T1 estimation capability, and the potential for future expansions of LiverScope
capability to include assessment of liver disease activity and damage, could be transformational to the medical
care of patients with known or suspected NAFLD. This technology could support POC and mobile clinical
application in numerous contexts of use, including early detection, diagnosis, staging, monitoring, and
treatment response assessment; early intervention to prevent downstream hepatic and extrahepatic
complications of NAFLD; large-scale epidemiology studies to better understand the prevalence and genetics of
NAFLD; and more efficient screening, enrollment, and execution of clinical trials to accelerate drug discovery.

Public health relevance
PROJECT NARRATIVE Livivos aims to improve care for liver disease by introducing LiverScope®, a low cost, self-contained, portable, table-top device using novel, noise-free, advanced magnetic resonance-based technology to assess quantitative biomarkers of nonalcoholic fatty liver disease (NAFLD) in research and clinical settings. The goal of this study is to demonstrate feasibility and preliminary performance characteristics of estimating liver T1 relaxation time, a biomarker of liver fibrosis and possibly also inflammation, to support submission of a future Phase 2 study intended to result in FDA 510(k) clearance and subsequent commercialization. This technology could support point-of-care and mobile clinical application in numerous contexts of use, including early detection, diagnosis, staging, monitoring, and treatment response assessment; timely intervention to prevent downstream hepatic and extrahepatic complications of NAFLD; unprecedented, global epidemiology and genetics studies; and more efficient execution of clinical trials to accelerate drug discovery.